Image informatics tools for curation and prognostic modeling in pediatric brain tumors

ABSTRACT: A significant challenge for ~4,000 new cases of childhood brain tumors every year is to minimize
the risk of overtreatment or undertreatment, which is responsible for the wide disparity in patient outcomes.
Despite revised molecularly informed risk-stratification, prognosis for many children with brain cancer remains
poor with morbid long-term sequelae associated with aggressive chemoradiation. Given the wide availability of
MRI within the clinical workflow, there is an opportunity for developing reliable, complementary image-based
prognostic companion diagnostic tools for pediatric brain tumors and thus provide critically needed and
clinically actionable information for (i) identifying high-risk cases who are most likely to receive added benefit
from adjuvant & concomitant therapy, while (ii) enabling therapy de-escalation in low/standard-risk cases.
Image-based companion prognostic models using machine-learning (ML) and deep learning (DL) have shown
significant promise in adult tumors, including in brain tumors. However, biological differences and considerably
limited data in pediatric brain tumors poses challenges in adopting similar ML/DL pipelines for prognostic
modeling. These include: (1) ensuring “quality-controlled” cohorts that account for reduced tissue contrast, noise,
and resolution issues in pediatric scans; (2) lack of expert-vetted, deeply annotated pediatric brain tumor scans;
and (3) paucity of radiomics descriptors (computerized extraction of sub-visual information from routine imaging)
designed to capture unique tumor manifestation in pediatric brain tumors while accounting for brain development.
In this U01 project, we propose to develop, validate, disseminate the first unified, community driven pediatric
brain tumor image informatics (PBTI2) toolkit, which will comprise three modules: (a) CuPed, a synergistic cohort
curation tool which will allow for efficiently triaging imaging scans to meet user-specified bounds on image quality,
as well as intelligently account for batch effects; (b) SegPed, an interactive human-in-the-loop segmentation tool
for creating deeply annotated pediatric MRIs, and (c) RaPed, a suite of specialized radiomics descriptors that
account for age and location specific morphometric differences in the growing brain structure, unique to pediatric
brain tumors. Leveraging our access to the Children’s Brain Tumor Network (CBTN), the validation of PBTI2 will
take place within two specific use-cases: (1) creating the largest repository of expert vetted, deeply annotated
pediatric brain tumor datasets of 3000+ CBTN MRI scans, and (b) building and validating an image-based
companion-prognostic model for survival stratification in medulloblastoma tumors via CBTN and a completed
clinical trial cohort (N>500). With integration of PBTI2 modules into NCI platforms such as IDC, 3D Slicer, FeTS,
and public release of expert-vetted segmentations and radiomic features, PBTI2 will have far-reaching
implications in future diagnostic/prognostic models for improving outcomes in this underserved population.

Public health relevance
RELEVANCE: This project will result in development of PBTi2, a new image informatics toolkit to systematically overcome challenges in developing image-based companion-prognostic tools for pediatric brain tumors. By leveraging our access to one of the largest multi-institutional pediatric brain tumor repositories, along with the proposed integration of PBTi2 modules into different NCI platforms as well as the public release of expert-vetted segmentations and radiomic features, PBTi2 will have far-reaching implications for efforts in diagnostic/prognostic predictive models for improving patient outcomes in this underserved population.